Cognitive, Socioaffective, and Neural Development Following Fetal Zika Virus Infection

Project Summary/Abstract
At its most extreme, fetal Zika virus infection causes microcephaly – the significant shrinking of the fetal brain
and skull. Accumulating evidence suggests that microcephaly is just one possible outcome of fetal Zika virus
infection, however, and that babies born with normal sized heads may have significant central nervous system
pathology. The long-term consequences of this pathology are unknown, leaving open the possibility of a
secondary epidemic resulting from compromised cognition and socioaffective processing that will occur as
babies born during the epidemic age. The proposed work takes the first step in developing an understanding of
the consequences of this pathology by mapping the cognitive and socioaffective of a cohort of nonhuman
primates infected with Zika virus as fetuses and a group of procedure matched, non-infected controls. We will
evaluate the extent to which maternal and fetal viremia influences cognitive, socioaffective, and neurological
outcomes. Because macaques develop approximately four times faster than humans, we will be able to
prospectively model pathology that arises – that is, we will be able to predict what pathology human babies,
infected with Zika virus during the 2015-2016 epidemic, will experience as they grow up. Developmental
modeling of this sort is critical for developing effective interventions and treatments to encourage healthy
development and ameliorate psychopathology.

Public health relevance
Project Narrative This project will map the cognitive and socioaffective development of a cohort of nonhuman primates exposed to Zika virus in utero, in order to understand the challenges that face babies born during the 2015-2016 Zika virus epidemic. Nonhuman primate models allow for precise experimental control and access to neural tissues that is not available using only human samples. Further, because they develop approximately four times faster than humans, their development will quickly outpace that of babies born during the epidemic allowing us to predict what cognitive and socioaffective pathology may develop in children before it actually occurs.